Cancer Center Support Grant

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
OVERALL - PROJECT SUMMARY/ABSTRACT
The Montefiore Einstein Cancer Center (MECC), formerly known as the Albert Einstein Cancer Center, is the
fourth oldest NCI-designated cancer center in the U.S., having received NCI designation in 1972, and is now
celebrating its 50th year as an NCI designated cancer center. The overarching mission of MECC is to reduce the
burden of cancer in the Bronx and the nation through exceptional cancer research, education & training,
community outreach and engagement, and provide compassionate care for all including historically marginalized
communities that face heightened inequities in cancer and social determinants of health. Our Bronx catchment
area is home to 1.5M residents, and we serve one of the most racially and ethnically diverse populations and
one of the poorest communities in the U.S. To achieve our mission, MECC has 132 members organized into 4
Research Programs (RPs): Tumor Microenvironment and Metastasis (TMM), Stem Cell and Cancer Biology
(SCCB), Cancer Therapeutics (CT), and Cancer Epidemiology, Prevention, and Control (CEPC). The science of
these RPs is facilitated by 8 Shared Resources (SRs). All MECC RPs conduct cancer-focused research that is
relevant to the Bronx catchment area, and this science is greatly facilitated by the Office of Community Outreach
and Engagement (COE). The MECC COE is the main vehicle by which our Center understands, engages with,
and serves the needs of the underserved communities in our catchment area, and it plays a critical role in
facilitating the Center’s research that is relevant to the catchment area. Our Cancer Research Training and
Education Coordination (CRTEC) programs are well integrated with the four RPs and with our COE initiatives.
Moreover, the MECC is focused on creating a diverse pipeline for the next generation of cancer scientists and
clinicians. With the arrival of the new Director in October 2020, MECC has engaged in several transformative
processes, which include the following: (1) created a new MECC Strategic Plan; (2) appointed 9 new Senior
Leaders and 8 Program Leaders; (3) restructured the RPs to more tightly align and focus cancer research and
to more effectively foster transdisciplinary collaboration and translational research; (4) tightened MECC
membership criteria to enhance cancer focus; (5) formed 7 new internal MECC committees and 2 new MECC
external committees to enhance organizational capabilities; (6) created Offices for COE and CRTEC; (7)
appointed a new Associate Director for Diversity, Inclusion, and Equity (DEI); (8) created a new Department of
Oncology that is more tightly aligned with MECC; (9) formed a Cancer Service Line Executive Committee and a
new funds flow model to MECC; (10) recruited 42 new faculty that span the entire spectrum of cancer-focused
science; and (11) established a Women’s Task Force to enhance gender balance and diversity.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
The Montefiore Einstein Cancer Center (MECCC) seeks to reduce the burden of cancer through its basic, clinical, and population-based research and to take the scientific discoveries and bring them into clinical initiatives for the prevention, detection, and treatment of cancer. This is accomplished through MECCC’s four established research programs and eight shared resources. MECCC seeks to understand the molecular and epidemiologic basis for various cancers that arise in Bronx, the Center’s main catchment area.